Administrative Core

Through the activities in this Administrative Core, we will provide scientific and administrative leadership and
oversight for this highly collaborative U19 proposal that will deploy multiple genomics-enabled approaches to
investigate viral, bacteria fungal, and parasitic pathogens associated with high mortality and morbidity, analyze
co-infections that may alter disease outcome, and emphasize the identification of novel drug targets for those
infections that are difficult to treat. The components of this GCID will include four interacting Research Projects
that will make use of our state-of-the-art Technology and Data Management and Dissemination Cores. To
support these integrated activities we will (i) establish an Executive Committee that will be responsible for
overall scientific direction and progress of all Research Projects and Cores, (ii) provide general administrative
support and fiscal accountability at the level of each Research Project and Core, (iii) establish mechanisms for
regular communication with NIAID, the external Steering Committee, and the other GCIDs, (iv) engage in
outreach and training activities in order to transfer genomics expertise from our GCID to the infectious disease
community, and (v) in consultation with NIAID, establish a mechanism for funding Collaborative Pilot Projects
across GCIDs that will further advance the development of novel technologies or explore high-priority research
topics in infectious disease.